Humoral Immunity by Anergic B cells

PROJECT SUMMARY
Not all autoreactive B cells are censored by central tolerance during their development. Thus,
mechanisms of B cell anergy are essential for the functional silencing of autoreactive B cells that exist in the
periphery in both humans and mice. However, it remains unclear why this poorly defined process of
immunological tolerance allows for the temporary retention of autoreactive B cells in the periphery given that,
under certain genetic and environmental settings, these cells can contribute to autoimmunity. Indeed, anergic
B cells can be released from their functionally inert state but requires unique circumstances (e.g., strong TLR
stimulus and highly multimerized antigen), which could presumably occur during an uncontrolled infection. As
such, we propose that autoreactive anergic B cells may serve as a reserve population able to respond to
pathogens not contained by an initial immune response and particularly for pathogens that aim to evade the
immune response through molecular mimicry of self-antigens. Accordingly, work from our lab has recently
evaluated if autoreactive B cells that are normally silenced by immune tolerance can contribute to a protective
cross-reactive antibody response. To accomplish this we used both autoimmune prone B6.Sle123 mice and
wild-type mice treated with pristane, a treatment characterized to impair tolerance and promote autoantibody
production. These mice were immunized with HIV envelope protein (Env) and immune sera was found to
neutralize tier 2 genetic subtypes of clinically relevant HIV-1, a pathogen proposed to exploit immune tolerance
in order to evade the immune response. Furthermore, from these mice we isolated Env-specific neutralizing
monoclonal antibodies that also recognize the H2A histone protein. Thus, the goal of this proposal is to use
mouse and humanized mouse models to identify the nature and mechanisms that facilitate this antibody
response by peripheral autoreactive B cells and to establish conditions that experimentally breach tolerance
and promote cross-reactive autoantibody responses by anergic B cells.

Public health relevance
NARRATIVE While most B cells that express an autoreactive antigen receptor are culled from development to prevent their potential contribution to autoimmune disease, not all autoreactive B cells are eliminated and `escaped' autoreactive B cells can be found in the peripheral lymphoid organs of healthy adults and wild type mice. Given the capacity of these autoreactive B cells to contribute to disease, it is not clear why the immune system does not cull these cells in the bone marrow unless there may be circumstances where they may be useful. The goal of this application is to understand the mechanisms and conditions that normally restrain these cells from causing autoimmune diseases or allow them to participate in a protective antibody response.